CYP4F Enzymes Regulate N-Acyl Amino Acid Signaling in Humans

PROJECT SUMMARY
Obesity and obesity-related type 2 diabetes (T2D) pose major health threats in the US, however the early
pathophysiology of these diseases remain incompletely defined. Blood-borne lipid signaling molecules called
lipokines are an emerging class of endocrine factors that control systemic energy and glucose homeostasis
and offer significant potential as therapeutic targets in human metabolic disease. We recently discovered that
an unusual family of lipokines that consist of fatty acid-amino acid conjugates called N-acyl amino acids
stimulate energy expenditure and thereby reduce body weight and improve glucose tolerance in murine
models of obesity. To define the role of N-acyl amino acids in human biology, we recently used mass
spectrometry (MS) methods to measure N-acyl amino acid family members in 2,351 participants of the
Jackson Heart Study (JHS) and found that individual N-acyl amino acids are strongly associated with
decreased risk of future T2D, coronary heart disease, and heart failure. To identify the genetic determinants of
these disease-associated N-acyl amino acids in humans, we performed genome-wide association studies on
plasma levels of each N-acyl amino acid in JHS and unexpectedly identified a strong association between the
CYP4F gene locus and specific N-acyl amino acids. We experimentally validated this association by
demonstrating that CYP4F2 directly hydroxylates specific N-acyl amino acids using cell models. Moreover, we
demonstrated that this reaction competitively inhibits the hydroxylation of CYP4F2 canonical enzymatic
substrates such as arachidonic acid and other key eicosanoids, and produces numerous previously unknown
lipid metabolites, including several that structurally resemble anti-diabetic fatty acid hydroxy fatty acids
(FAHFAs). Based on these findings, we hypothesize that N-acyl-amino acids serve as endogenous substrates
of CYP4F enzymes in humans and that this biochemical interaction has important functional consequences on
downstream lipid signaling networks and cellular metabolic function. In Specific Aim 1, we will biochemically
characterize N-acyl amino acids as substrates and competitive inhibitors of CYP4F enzymes using cultured
primary human hepatocytes and recombinant CYP4F proteins. In Specific Aim 2, we will define the functional
consequences of N-acyl amino acid inactivation by CYP4F hydroxylation on cellular metabolism using cultured
primary human hepatocytes. In Specific Aim 3, we will characterize novel N-acyl amino acid downstream
products of CYP4F hydroxylation as biomarkers of cardiometabolic disease in two, diverse, large human
population studies. Successful completion of this project will establish a biochemical basis for the association
of the CYP4F gene locus with N-acyl amino acids in humans and will serve as a critical first step toward
understanding the physiologic functions of N-acyl amino acids in human metabolism. Characterization of N-
acyl amino acids and related pathways may ultimately provide new insight into therapeutic strategies for the
treatment and prevention of obesity and T2D.

Public health relevance
PROJECT NARRATIVE Obesity and obesity-related type 2 diabetes (T2D) pose major health threats in the US. We recently discovered that a family of signaling molecules in the blood called N-acyl amino acids have anti-diabetic properties in animal models of obesity and are strongly associated with metabolic disease in humans. In this project, our goal is to use new methods in the laboratory to study a pathway that regulates the levels of these disease- associated compounds in the blood in order to improve our understanding of metabolic disease in humans, and to identify potential new pharmacological targets for the prevention and treatment of obesity and T2D.